Effects of HSV-1 reactivation from latency on aspects of neural precursor cells neurogenesis and accumulation of Alzheimer's molecular hallmarks

7. ABSTRACT
Alzheimer's disease (AD) is the leading neurodegenerative cause of dementia. Primary neuropathological
lesions of AD are extracellular plaques of fibrillized β-amyloid (Aβ) peptides and intracellular neurofibrillary
tangles of hyper-phosphorylated tau (p-tau) protein. The impairment of adult neurogenesis is an early event
in the development of AD. A recent hypothesis (“pathogen hypothesis”) proposes that herpes simplex virus
1 (HSV-1) plays a relevant role in the onset of AD. A consequence of HSV-1 reactivation in murine central
nervous system (CNS) is cognition deficits caused by impaired NPCs neurogenesis in the hippocampus.
HSV-1 infection results in Aβ42 accumulation in the NPCs in the hippocampus and these mice demonstrate
impaired neurogenesis linked to amyloid-β protein accumulation.
In the present proposal, we aim to specifically investigate the consequences of HSV-1 reactivation on
neuronal differentiation of NPCs and the generation of AD molecular hallmarks in cells undergoing viral
reactivation. We propose the following Supplemental Aims: 1) Analysis of the effects of HSV-1 reactivation
on aspects of neurogenesis, such as NPCs proliferation and differentiation; 2) Analysis of accumulation of
Aβ peptides and hyperphosphorylation of tau in NPCs during HSV-1 reactivation by combined Fluorescent
in Situ Hybridization and Immunohistochemistry (FISH-IHC).
Supplemental Aim 1 is relevant to AD because in vivo studies suggest that neurogenesis is impaired during
early stages of Alzheimer's disease and may underlie, at least in part, cognition deficit. Although abnormal
NPCs neurogenesis and cognitive decline have been described in a mouse model of HSV-1 reactivation, it
is not known whether these outcomes can be attributed to viral reactivation in NPCs.
Supplemental Aim 2 is relevant to AD because NPCs isolated from a murine model of familiar Alzheimer’s
disease exhibit hyperphosphorylation of tau. The results from this in vivo model indicate that: i) tau
hyperphosphorylation is the main contributor to impaired neurogenesis; ii) Aβ levels do not seem to be the
primary factor in the alteration of NPCs neurogenesis. However, a recent study indicates that Aβ
accumulation in NPCs is the major contributor to impaired neurogenesis in a murine model of HSV-1
reactivation. Nevertheless, it is important to note that in this study the tau hyperphosphorylation in
NSCs/NPCs had not been investigated. We propose to investigate whether altered levels of Aβ or
hyperphosphorylated tau follows HSV-1 reactivation and whether the increased levels of one of these AD
molecular hallmarks may occur in NPCs undergoing to HSV-1 reactivation.

Public health relevance
8. PROJECT NARRATIVE Limited information exists regarding the role of HSV-1 infection in the pathogenesis of Alzheimer’s disease (AD). This project will employ an innovative model of human induced pluripotent stem cell-derived three-dimensional (3D) cultures of neuronal progenitor cells (NPCs). We will investigate if HSV-1 reactivation from latency affects aspect of neurogenesis and whether it leads to accumulation of AD-relevant molecules, amyloid-β and tau in NPCs. Clarifying the role of HSV-1 in AD could lead to prophylactic treatments targeting risk factors rather than established pathology.